Single Cell Genome-Wide Myeloid Response Profiling in Immunotherapy

Project summary
Tumor microenvironments are home to diverse immune cell types but current immunotherapeutic approaches
are focused largely on activating cytolytic T cells. The potential of other, myeloid lineage cells in fighting cancer
are hitherto much less explored. For example, we have a limited understanding of the complexity of myeloid
cell subtypes, we cannot fully discriminate between tumor-promoting and tumor-suppressing cells, and we lack
information about defined myeloid cell-associated molecular pathways that could be harnessed for therapy.
Here, we will use cutting-edge, unbiased single cell profiling to reveal unappreciated immunoregulatory
myeloid cell types, alongside in vitro and in vivo perturbations, to reveal unappreciated tumor-infiltrating
myeloid (TIM) cell populations and define their functional role in lung cancer. To this end, we will first determine
human TIM states, their correlation with clinical parameters, and whether these states are conserved between
human and mouse lung adenocarcinoma. We will specifically test the hypotheses that i) yet-unappreciated
myeloid cell states in tumors and peripheral blood of human patients correlate with patient survival (and
possibly other clinical parameters), and ii) genetically engineered mouse tumor models of lung
adenocarcinoma host conserved human TIM states and justify further animal studies of the function of these
states. Second, we will focus on so-called GN2 and GN3 neutrophil subsets, considering our initial data
showing their existence in both human and mouse lung tumors and their relevance to cancer progression
(Science, 2017 in Press and our unpublished data included in this application) and that neutrophils are
emerging as strong predictors of survival for diverse solid tumors and most notably lung cancer. We will
specifically test the hypotheses that i) GN2 and GN3 neutrophils have distinct tumor-promoting functions, and
ii) these subsets use specific molecular signaling pathways to foster lung cancer progression. To achieve our
goals, we will combine efforts of two labs with complementary expertise: tumor immunobiology and myeloid
cells (Pittet), and single cell RNA sequencing (scRNA-Seq) and theory/bioinformatics (Klein). We have further
teamed up with clinicians to obtain both blood samples and fresh tumor biopsies from lung cancer patients (our
preliminary data are also included in this application). Overall, the approaches and resources developed here
could have major implications for developing new and more efficient immunotherapies. Also, by targeting the
immune system beyond T cells, we will exploit the diversity of non-redundant immune components as a way to
overcome limitations of current treatment options.

Public health relevance
Project narrative This grant applies a new, powerful method to profile the states of all immune cells in lung adenocarcinomas. We will use this approach to determine all tumor-infiltrating myeloid (TIM) cell states!in!humans and their correlation with clinical parameters. By profiling TIMs in mouse models, we will further determine the properties of TIMs that can be justifiably studied in mice, and then dissect the relevance and mechanisms of action of two TIM subsets and three signaling pathways that we have found to be specific to TIMs.